USING DRUG SELF-ADMIN. IN RATS TO EVAL. DRUGS OF ABUSE AND PHARMACOTHERAPIES FOR

The contractor shall evaluate potential pharmacotherapies for cocaine abuse. Determine the ability of potential treatmetn medications to alter the reinforcing effects of cocaine as assessed by the rat self-administration procedure.